Reducing Ultra-Processed Foods In Seattle Public Schools

PROJECT SUMMARY
In the United States (U.S.), the majority of children consume high levels of ultra-processed foods (UPFs),
which are ready-to-eat industrial formulations of foods that are characterized by high levels of added sugars,
unhealthy fats, salt, and chemical additives. This is of concern as UPFs are associated with poor dietary quality
and increased risk of obesity and cardiometabolic risk factors in children. Schools can be an ideal setting to
reduce students’ exposures to UPFs, but many schools lack the equipment, resources, and capacity to serve
unpackaged, scratch cooked meals. Therefore interventions to address these barriers are essential to
providing fewer UPFs in schools. In this proposal, we plan to implement a sustainable intervention to reduce
the amounts of UPFs served throughout Seattle Public Schools, the largest school district in Washington State.
First, our intervention will expand scratch-cooked meals by investing in kitchen equipment and staff trainings to
replace pre-packaged, ultra-processed foods and reduce the amount of foods that may have contaminants
(e.g., heavy metals). Second, we will source locally grown produce and proteins in a sustainable manner to
enhance meal quality while supporting regional farmers. Lastly, we will engage students in taste tests and
nutrition education to ensure high acceptability (and thus long-term sustainability) of the changes made. Food
samples will be collected at baseline (pre-intervention) and then throughout the study period. Overall, our
evaluation will make important contributions towards understanding the impact of limiting UPFs in schools and
will make a powerful, sustained impact across Seattle Public Schools.

Public health relevance
PROJECT NARRATIVE Ultra-processed food (UPF) consumption rates have been increasing among children in the U.S. over the past several decades, which may increase their risk of poor health outcomes. As many children rely on school meals for up to half their daily energy intake, schools are an ideal setting to implement changes to reduce exposures to UPFs and potential associated contaminants. In this intervention, we will replace UPFs with scratch-cooked meals through investments in kitchen equipment and staff trainings as well as the integration of more locally grown foods, and engage students to ensure the acceptability and long-term sustainability of the healthier foods offered.